AI-Enhanced Virtual Reality Cognitive Behavioral Therapy to Reduce Anxiety and Improve Quality of Life in Patients with Inflammatory Bowel Disease: A Multicenter Pilot and Feasibility Study

PROJECT SUMMARY
Anxiety is a common comorbidity in inflammatory bowel disease (IBD), affecting up to 35% of patients, yet current
IBD treatments focus primarily on clinical markers of disease activity and do not adequately address the mental
health burden. This gap leads to decreased health-related quality of life (HRQoL), poor patient outcomes, and
increased healthcare utilization. Despite the prevalence of anxiety in IBD, access to evidence-based treatments
such as Cognitive Behavioral Therapy (CBT) is limited, particularly for patients in rural or underserved areas.
Virtual reality (VR) and artificial intelligence (AI)-enhanced CBT represents a novel, scalable solution to
overcome these barriers, offering a self-administered, immersive therapy experience that is accessible from the
patient’s home.
This proposal aims to conduct a pilot randomized controlled trial (RCT) to assess the feasibility and clinical
impact of an 8-week home-based VR/AI CBT program versus sham VR control in 76 patients with IBD and
anxiety. The study will be conducted at two leading IBD centers: Cedars-Sinai and the University of Chicago.
Using the NIH-endorsed ORBIT Model for Developing Behavioral Treatments, our VR/AI CBT program has been
refined in Phase I, and we are now ready to proceed with Phase IIa/b pilot testing. The program is designed to
improve anxiety, HRQoL, and potentially inflammatory biomarkers in IBD patients.
The following specific aims will be addressed:
¨Aim 1: Establish the feasibility of using an 8-week VR/AI CBT program in IBD patients with anxiety.
¨Aim 2: Acquire preliminary data on the clinical impact of the VR/AI CBT program compared to sham VR,
focusing on improvements in anxiety, HRQoL (measured by IBDQ), and IBD symptoms (measured by PRO2).
¨Aim 3: Acquire exploratory data on the impact of VR/AI CBT on inflammatory biomarkers, specifically serum
C-reactive protein (CRP) and fecal calprotectin (fCal).
If successful, this pilot study will provide the foundation for a fully powered Phase IIc efficacy trial, advancing the
development of scalable, evidence-based mental health interventions in IBD. By addressing both psychological
and physiological dimensions of IBD, VR/AI CBT has the potential to significantly improve patient outcomes and
fill a critical unmet need in the management of IBD.

Public health relevance
PROJECT NARRATIVE This project aims to develop and test a scalable, self-administered virtual reality (VR) and artificial intelligence (AI)-enhanced cognitive behavioral therapy (CBT) program to reduce anxiety and improve health-related quality of life (HRQoL) in patients with inflammatory bowel disease (IBD). By addressing both the psychological and physiological aspects of IBD, this research has the potential to improve patient outcomes and reduce healthcare utilization, especially in underserved populations with limited access to mental health resources. This study aligns with the NIH’s mission to enhance health and reduce illness by developing innovative, accessible therapies for patients with chronic conditions.